Concept Representation in the Human Brain

Concepts are the building blocks of human cognition, providing the basic content for language, episodic
memory, social interaction, planning, and many other essential capabilities. Modern evidence suggests that
human conceptual knowledge is represented in a widely distributed and hierarchically organized system
involving much of the brain. Despite the central importance of this cognitive domain, there are large gaps in our
understanding of very fundamental issues concerning how concepts are represented and organized at a
systems level. This project addresses several of these gaps using a novel, high-dimensional, biologically
based model of word meaning that captures the extent to which a concept is derived from various types of
sensory, action, emotional, spatial, temporal, and cognitive experiences. We use this model in a series of
information-based analyses of fMRI data and multivariate analyses of lesion-deficit correlations in patients with
stroke. Our main hypothesis is that much of conceptual knowledge is represented in abstract form within
content-specific experiential networks and multi-level convergences between these networks. Aim 1 is to clarify
the detailed architecture of these hierarchical convergences, including intermediate crossmodal networks that
we hypothesize arise in the brain due to proximity of neural processing streams and systematic covariation
between experiential dimensions. Aim 2 is to test the hypothesis that event concepts (e.g., PARTY, ACCIDENT,
SNEEZE) are primarily represented in inferior parietal convergence networks due to strong contributions from
motion, action, spatial, and temporal experiences in the formation of these concepts, whereas object concepts
have stronger representation in temporal lobe convergence networks that capture static multisensory
experiences. Aim 3 is to clarify how concept categories are differentially represented and how this organization
gives rise to category-related impairments in patients with focal brain damage. We hypothesize that neural
representations of both concrete and abstract categories emerge from differently weighted mixtures of
experiential information at high levels in the representational hierarchy. The high-dimensional, experiential
representation of word meaning on which these hypotheses are based, combined with advanced fMRI
techniques for mapping information content, makes it possible to address these basic knowledge gaps
systematically for the first time. Combining state-of-the-art lesion-deficit correlation analyses with these healthy
brain fMRI studies provides a powerful means of establishing causal links between fMRI activity patterns and
successful concept retrieval. Understanding this large, complex, and particularly human brain system has far-
reaching implications for understanding a range of neurological conditions that impair knowledge
representation and retrieval, is likely to be transformative in the realm of functional mapping for brain surgery,
and will be a prerequisite for developing rational and effective rehabilitation strategies for such patients,
including future therapies involving modulatory stimulation, brain-machine interfaces, and biological repair.

Public health relevance
Concept knowledge, such as knowledge of the features that define different kinds of objects, people, places, and events, is essential to every aspect of human life, but our understanding of how the brain stores this knowledge is very incomplete. This project aims to produce the first detailed maps showing how concepts are stored and organized into categories in the brain. This information will be useful for minimizing risks of brain surgery and provide an essential foundation for designing better rehabilitation strategies in people with brain damage.